Multiparametric deep tissue microscope for in vivo and in vitro imaging

Project Summary:
Every cell and tissue biomedical research program requires microscopic visualization of research specimens.
Some of this need can be addressed by routine widefield and confocal microscopy of relatively thin (< 50 um)
tissue slices or tissue culture. However, biological understanding of molecular, cell and tissue-level dynamics
has been uniquely enabled by the recent explosion of advanced, multi-parametric microscopy procedures for in
vivo and ex vivo imaging. These procedures include multiphoton microscopy combined with harmonically
generated signals (SHG) for imaging in thick (100s of microns) tissue and solid tumors, expressing multiple
fluorescent proteins, as well as for deep (>1 mm), high resolution imaging of optically cleared tissues (e.g.
Clarity, iDISCO) stained with multiple fluorescent markers. These techniques are now a required part of
contemporary biomedical cell and tissue research. To be applied successfully, these methods require a
versatile, advanced imaging system that incorporates fast scanning, multi-photon and 1-photon excitation at
multiple wavelengths, high sensitivity and spectral selectivity over multiple detection channels, rapid imaging,
and environmental control. The demands of these state-of-the-art microscopy methods for both specialized
equipment and specialized expertise often outstrip the resources available to individual research laboratories.
As such, these needs are best met with a shared instrument housed in a shared resource facility. For these
reasons we are requesting funding to replace Stanford University's Cell Sciences Imaging Facility's 12-
year-old in vivo multi-photon/confocal microscope (Leica SP5) with the new, state-of-the-art Stellaris 8
DIVE microscope. This combined multi-photon, confocal, in vivo, and ex vivo as well as in vitro imaging
microscope will be a shared resource located in a well-established, multi-user light and electron microscopy
facility: The Cell Sciences Imaging Facility (http://microscopy.stanford.edu). This facility is accessible to
Stanford University's entire research community as well as surrounding biotech companies. The Stellaris 8
DIVE microscope will support research projects from 11 users, 10 of which are NIH funded. Their studies
investigate critical functional and structural questions in a variety of model organisms and tissues and cover
areas of biomedical research with implications for diverse aspects of human health and disease. These
projects include: clonal fate and linage tracing of stem cells and tumor initiating cells, interrogation of the
alveolar stem cell niche, molecular and cellular mechanisms of small cell lung and basal cell skin cancers
development, characterization of skeletal stem cells in osteogenesis, characterization of the bone marrow
microenvironment, gene therapy for inherited diseases and the biophysics of touch as well as characterizing.
All these projects critically require advanced instrumentation for imaging live and fixed tissue and cell samples,
a need which can only uniquely be met by the requested Leica Stellaris 8 DIVE microscope.

Public health relevance
Project Narrative Relevance: The studies currently being undertaken in a variety of model organisms and tissues by the NIH user group researchers are critical to understanding the in vivo micro-environments of healthy and diseased tissues in areas of biomedical research that have implications for diverse aspects of human health and disease ranging from the renewal and differentiation of stem cells, the cellular and molecular basis of sensory biology, to cancer metastasis in a variety of tissues, as well as tissue regeneration and healing. To improve and advance our understanding of these diverse processes we require a fast, combined multi-photon and confocal microscope that is specifically designed for deep, multi-parametric in vivo and ex vivo as well as in vitro tissue and cell imaging using ultra-fast pulsed laser for simultaneous and sequential imaging of a wide variety of expressed fluorescent proteins and endogenous signals.